Management of Sickle Cell Disease-Related Pain in Children

DESCRIPTION (provided by applicant): Sickle cell disease (SCD) is one of the most common genetic disorders in the US. Pain is the most common cause of acute morbidity in children and adults with SCD. Pain episodes are periodic, self-limited but often excruciating events that can last hours to days, sometimes weeks if inadequately treated. Studies on SCD-related pain have primarily focused on adults, therefore, the National Heart, Lung and Blood Institute identified acute pain management and prevention as a high-priority area for research in children. Most pain episodes are managed at home for children with SCD, yet there are no controlled studies examining the management of pain in this setting. In addition, there is growing evidence that pain is frequently under-treated at home. For more severe pain episodes, patients with SCD often rely on care in the emergency department (ED). Despite published protocols recommending rapid assessment and treatment, children with SCD experience significant delays and variation in the treatment of their pain. From the PI's qualitative work with parents of children with SCD, parents are often overwhelmed by the prospect of managing their child's pain at home. They also report delays in the treatment of their child's SCD- related pain in the ED. Parents believe that the use of an individualized pain plan would improve the caregiver's ability to prevent and manage their child's SCD-related pain. Written, symptom-based, management plans have been proven effective in treating chronic diseases, such as asthma and cancer-related pain. The specific aims of this project are to: 1) Design and conduct a national survey of directors of pediatric SCD or hematology programs and the division chiefs of pediatric emergency medicine to understand if, and how, pain protocols or other methods are used in the home and ED settings for the management of SCD- related pain in children; 2) Convene an expert panel to develop quality indicators for the prevention and management of acute SCD-related pain in children in the home and ED settings using the Modified Delphi method, and to refine an individualized written pain plan for use in children with SCD; and 3) Perform a pilot randomized controlled trial of children with SCD aged 5 to 12 years to evaluate the feasibility and efficacy of using an individualized written pain plan in the home and ED settings. In addition to acquiring quantitative research skills through the proposed research plan, the candidate will gain knowledge in the management of children with SCD and pain; receive instruction on the cultural aspects of health care, advanced biostatistics, and study design through additional coursework; and learn about systems approaches to caring for children with chronic illness. Information and experiences gained from this project will be used to design a multicenter randomized controlled trial to examine the effect of an individualized pain plan on the health care utilization, physical function, and quality of life of children with SCD.

Public health relevance
Project Narrative Sickle cell disease (SCD) is one of the most common genetic disorders in the US. Pain episodes are the most common cause of acute morbidity in children with SCD, and typically increase in frequency and severity as they grow older. The public health implications of this proposal are that better management of SCD-related pain will result in improved health, educational, and quality of life outcomes in these children, which will allow them to lead more productive lives as adults. __SpecificAimsTextDelimiter__ 10. Specific Aims Sickle cell disease (SCD) is one of the most common genetic disorders in the United States1 affecting approximately 80,000 children and adults predominantly in the African American and Hispanic communities.2 Pain is the most common cause of acute morbidity in children and adults with SCD.3 Pain episodes are periodic, self-limited, but often excruciating events for patients that can last hours to days, sometimes weeks if inadequately treated.4 In SCD, pain management is complicated by the need for higher doses of medications to achieve analgesia due to severe pain and opioid tolerance, and by the altered duration of action of medications due to the unique physiology associated with SCD.5 Studies on SCD-related pain have primarily focused on adults with SCD, therefore, the National Heart, Lung and Blood Institute (NHLBI) identified acute pain management and prevention as a high-priority area for clinical research in children in 2008.6-7 Although most pain episodes are managed at home for children with SCD,8 there are no controlled studies examining the management of pain in this setting.9 In addition, there is evidence that pain is frequently under- treated at home. The American Pain Association guidelines stress the need to provide treatment that results in a 50% reduction in SCD-related pain initially, with continued assessment and titration as needed to expedite resolution of the pain episode.4 However, a recent study of children and adolescents with SCD found that they were most often treated with a single, non-opioid analgesic medication which reduced pain intensity levels by only 13-26%.10 Such findings are supported by our preliminary data which indicate that parents often find managing SCD-related pain at home to be a complex and overwhelming task. For more severe pain episodes, patients with SCD often rely on emergency department (ED) care to provide relief. However, the ED often underutilizes analgesics,11-13 especially for children.14 Despite published clinical practice guidelines recommending rapid assessment and treatment of acute SCD-related pain in the ED,4, 15 children with SCD experience significant delays16 and variation17 in the treatment of their pain. From my qualitative work with parents of children with SCD,18 I have found that parents are often overwhelmed by the prospect of managing their child's pain at home. They also report delays in the treatment of their child's SCD-related pain in the ED. Parents believe that the use of an individualized pain plan would improve the caregiver's ability to prevent and manage their child's SCD-related pain. Written, symptom-based, management plans have been proven effective in treating chronic diseases, such as asthma and cancer- related pain.19-20 The specific aims of this project are to: 1. Design and conduct a national survey of directors of pediatric SCD or hematology programs and the division chiefs of pediatric emergency medicine to understand if, and how, pain protocols or other methods are used in the home and ED settings for the management of SCD-related pain in children; 2. Convene an expert panel to develop quality indicators for the prevention and management of acute SCD- related pain in children in the home and ED settings using the Modified Delphi method, and to refine an individualized written pain plan for use in children with SCD; and 3. Perform a pilot randomized controlled trial (RCT) of children with SCD aged 5 to 12 years to evaluate the feasibility and efficacy of using an individualized written pain plan in the home and ED settings. My hypothesis is that most pain management strategies are not tailored to a specific patient based on their previous experience(s). In addition, I hypothesize that the prevention and management of SCD-related pain could be significantly improved through the use of individualized written pain plans for children, both at home and in the ED settings, as seen with other chronic conditions in childhood.19 Finally, I hypothesize that use of an individualized pain plan for children with SCD would lead to fewer pain episodes, and shorter duration for the pain episodes that do occur. This in turn would result in increased school attendance, decreased health care utilization, and improved quality of life for the child with SCD, and decreased stress for their parents. Ultimately, I will use the information gained from these studies to design and seek funding for a multicenter RCT to examine the efficacy of an individualized written pain plan on the health care utilization, physical function, and quality of life of children with SCD.